Development of non-opioid, non-addictive analgesics for treating neuropathic pain

Project Summary
Safe and effective treatment of neuropathic pain remains a challenging medical problem. First- and second-line
treatments show modest, variable efficacies in treating neuropathic pain and carry serious liabilities. Orthosteric
CB1R agonists like delta-9-tetrahydrocannabinol show (pre)clinical efficacy in suppressing neuropathic
nociception but also produce unwanted side-effects (e.g., tolerance, physical dependence, psychoactivity).
CB2R agonists (GW842166X, S-777469, and JBT-101) have not shown efficacy in clinical trials in other
indications and have not been tested for efficacy in people in therapeutic indications supported by the preclinical
literature. We have successfully identified novel “dualsteric modulators” having a unique pharmacological
phenotype characterized by activity as both a non-psychoactive cannabinoid CB1R allosteric agonist-positive
allosteric modulator (ago-PAM) and a CB2R agonist. Our central hypothesis is that such dualsteric ligands
leverage the therapeutic advantages of allosteric GPCR regulation of both cannabinoid receptors and provide
effective broad-spectrum analgesia without abuse liability and other CB1R-mediated side effects. We will unite
the complementary and non-overlapping expertise of five different laboratories to conduct experiments proposed
under three Specific Aims. Aim1 will design and synthesize a series of novel N-arylindole and 2-cycyloalkyllindole
analogs as CB1R/CB2R ago-PAMs with improved pharmacological profiles compared to our lead compounds,
GAT1102 and GAT588. Aim 2 will perform in vitro pharmacological characterization and target-engagement
studies and in vivo ADME/PK profiling of key CB1R/CB2R ago-PAMs to eliminate potential liabilities and identify
compounds with suitable drug-like properties for in vivo studies. Aim 3 will perform in vivo evaluation of optimized
CB1R/CB2R ago-PAMs with suitable drug-like properties for suppressing nociception in mechanistically distinct
neuropathic pain states. We postulate that our dualsteric ligands will suppress both sensory and negative
affective dimensions associated with neuropathic nociception without unwanted side effects of orthosteric CB1
agonists. Successful validation of our innovative first-in-class therapeutic strategy offers the potential to change
the face of pain management.

Public health relevance
Project Narrative Neuropathic pain, including that produced by traumatic nerve injury or toxic challenges, produces adverse behavioral hypersensitivity (i.e., mechanical and cold allodynia) as well as negative affective disturbances such as anxiety-like behavior. Conventional pharmacotherapies for pain due to nerve injury carry serious liabilities. We propose to develop first-in-class dualsteric ligands that combine allosteric modulation of cannabinoid CB1 receptors and CB2 agonist activity to suppress mechanistically distinct forms of neuropathic pain and associated negative affective symptomatology using medicinal chemistry, computational modeling, signaling assays, and in vivo characterizations of ligand efficacy and toxicity.